EFFICACY OF SB202026 IN PATIENTS SUFFERING FROM ALZHEIMERS

This study will compare the efficacy of three doses of SB202026 and placebo in enhancing cognitive function in patients with probable dementia of the Alzheimer's type.